Leadership and Administrative Core

REVISED Abstract Leadership and Administrative Core (LAC)
We propose to establish the Center for Health in Cognitive Aging – Joining Population Science and Health Promotion (CHECA) at University of Illinois Chicago (UIC) that will provide research and mentoring infrastructure for early-career faculty (Scientists) from various backgrounds. CHECA’s thematic focus is social and behavioral pathways to Alzheimer’s disease (AD) and AD-related dementias (ADRD) in the context of dementia care and caregiving. The Leadership and Administrative Core (LAC) will be central to the successful operations of the CHECA center. The LAC will develop and maintain a strategic vision for the CHECA to expand the workforce for AD/ADRD-related behavioral and social sciences research and to facilitate significant scientific advances in priority areas identified by the center (Aim 1). LAC will also manage a distinguished Executive Committee that will oversee the functioning of the Center and assist the MPIs in making scientific and administrative decisions relating to the Center ( Aim 2). The LAC will be responsible for assembling an External Advisory Committee to advise the Center on its REC (Aim 3) and implementing a systematic method, using the Executive and External Advisory Committee members and an appointed review panel, to develop, identify, review, and monitor pilot projects (Aim 4). LAC will also monitor all pilot projects, their findings, and impact in annual Center progress reports that will be submitted to NIA (Aim 5). Lastly, LAC will promote networking activities and strategic collaborations with private sector interests, non-profit organizations, research institutions, and government agencies to support translation activities ( Aim 6). The LAC will be co-led by Naoko Muramatsu, PhD, a population science researcher, and Tanvi Bhatt, PhD, an expert in clinical trials design and health promotion research. Their leadership experience and expertise are complementary, yet scientifically unique and highly suited for conducting activities of the LAC. The LAC will establish the Executive Committee, which will involve LAC co-leads (MPIs) as well as the leads of the REC (Benjamin Shaw, PhD, and Olusola Ajilore, MD, PhD), AnC (Michael Berbaum, PhD), and CLRC (David Marquez, PhD, and Uchechi Mitchell, PhD). LAC will invite key leaders/directors of the policy, academic, and practice communities in and outside the Chicagoland to form the External Advisory Committee.